Development in the Moment: Does Caregiver Sensitivity Drive Prefrontal Cortex Synchrony?

Every day, 4,000 babies are born into low socioeconomic status (SES) families in the U.S, and these children
face disproportionate risks to their language and emotional development. Despite these risks, some will
flourish. How do primary caregivers (parents and others) protect young children from SES risks outside of their
control? Behavioral studies suggest that real-time factors like caregiver sensitivity (moment-to-moment
attunement and responsiveness to a child’s needs) may protect children against larger SES risks like low
family income. Existing research suggests that caregiver sensitivity may function as a universal behavioral
mechanism driving child brain development across domains. However, the neural underpinnings of these
potential real-time mechanisms are unknown. Recent two-brain research suggests that prefrontal cortex neural
synchrony (coordinated caregiver-child brain activity) may link children’s socially contingent real-time
experiences to their development. However, it is unclear whether or how caregiver sensitivity drives
moment-to-moment prefrontal cortex synchrony between caregivers and young children, and whether
prefrontal cortex synchrony is linked globally to children’s language and emotion regulation skills.
To fill these research gaps, I will investigate two novel aims while building skills, knowledge, and methodical
training to advance toward an independent research career. In my first Aim, I test whether moment-to-moment
fluctuations in caregiver sensitivity drives moment-to-moment caregiver-child prefrontal cortex synchrony within
families. In my second Aim, I will evaluate the association between global prefrontal cortex synchrony and
children’s language and emotion regulation skills across families. I have already collected nearly all of the
necessary data for my analyses (57 of 60 families collected), and my sample is unusually racially and
socioeconomically diverse (majority families of color). Through training activities supported by my
collaborators, I will gain the necessary skills to continue investigating neural mechanisms of children’s early
development in the context of their close relationships and larger socioeconomic disparities.

Public health relevance
Four in ten young children in the United States are born into low-income families, and they face risks in kindergarten-readiness skills including language and socioemotional development. In this two-brain study of caregivers and children ages 2-6, I will investigate the real-time relationship between caregiver sensitivity (attunement, warmth, and responsiveness to a young child) and preschoolers’ prefrontal cortex synchrony, and further test the relationship between caregiver-child prefrontal cortex synchrony and child language and emotion regulation development. By uncovering moment-to-moment relational mechanisms of children’s learning and development, we can shape policies (e.g., paid parental leave, high-quality Pre-K, Head Start) that buffer young children against SES risks far outside of their families’ control.